Incidental Enhancement: Addressing a Neglected Policy Issue in Human Genome Editing

PROJECT SUMMARY/ ABSTRACT
The increasing pace and international diffusion of developments in human genome editing research have
prompted ongoing efforts to develop responsible governance for such research. One point of broad agreement
across these efforts is that human genome editing research should prioritize medical applications over attempts
to enhance human traits because of the moral concerns the latter would raise. What qualifies as human
enhancement and how to address issues that may arise in this arena remain uncertain. Moreover, several
influential reports expand their interpretation of medical applications beyond disease treatment to endorse
disease prevention as a goal for genome editing research. Basic human genome research and animal studies
aspiring to this goal are already underway. But preventing disease through human genome editing would
incidentally facilitate human enhancement applications in a variety of ways. If these translational research
efforts are penalized by policy concerns about those applications, then their preventive health benefits could be
lost. Conversely, society could be caught off guard by the emergence of genome editing applications that evoke
the very moral concerns that the policy line against enhancement is meant to forestall. To responsibly
anticipate these challenges, science policymakers will need to know more about the salience of enhancement
concerns in the context of preventive genome editing (PGE) research and how best to develop research
governance to address them. This project addresses these needs through the following research questions: 1)
How do the goals, incentives and values driving cases of preclinical PGE research affect the ways that its
incidental enhancement implications are interpreted and addressed for governance purposes? 2) How well
might different forms of research governance be expected to anticipate and address these different concerns?
3) Given the potential human health benefits of preventive genome editing research, what ethical weight
should science policy give to the various enhancement concerns? Answering these questions requires both
empirical research and ethical analysis. Aim 1 enlists scientists to examine the professional and social factors
that shape the trajectory of basic research relevant to preventive genome editing. Their perspectives will inform
a taxonomy of different ways of interpreting incidental enhancements for policy purposes, and preview of the
governance challenges they will raise. Aim 2 follows national and global genome editing policy groups to
capture the lessons of their experiences, in order to assess the relative merits of different approaches to
governance in dealing with incidental enhancement concerns. Both of these efforts will be drawn together in
Aim 3, to inform an empirically grounded ethical analysis of the policy choices facing those engaged in genome
editing research governance in different cases. The product of this project will be a set of case studies designed
to help science policy makers, the research community and the public anticipate the incidental enhancement
concerns that preventive genome editing research will pose.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because achieving the health benefits of preventive gene editing research will depend on governance that is responsive to public concerns. This project is relevant to NHGRI’s mission because of the role that new genomic knowledge will play in the policy challenges that the research proposed here helps address.